Antibodies as Drugs: New Horizons in the Therapeutic Use of Engineered Antibodies

ABSTRACT Support is requested for a Keystone Symposia conference entitled Antibodies as Drugs: New Horizons in the Therapeutic Use of Engineered Antibodies, organized by Drs. Christian Klein, Mark S. Cragg and Germaine Fuh. The conference will be held in Breckenridge, Colorado from April 7-11, 2019. Over the last twenty years, recombinant antibodies have been established into clinical practice for the treatment of diseases ranging from cancer, to autoimmune and infectious diseases. While the first approved antibodies were native IgG antibodies, in recent years the field has rapidly advanced and therapeutic antibodies in preclinical and clinical development now include many non-canonical formats including Fc- engineered antibodies, antibody drug conjugates, bispecific antibodies and antibody-like scaffolds. This Keystone Symposia conference aims to bring together experts in antibody therapeutics, engineering and mechanisms of action from industry and academia to discuss and review the state-of-the-art in the field and discuss their future potential. The conference will foster cross-fertilization between different engineering technologies and scientists from different therapeutic areas. This conference can also help to initiate collaboration on the development of state-of-the-art antibody therapies with the aim to improve therapeutic options for patients. For trainees and early career researchers, this conference provides an opportunity to gain insight into various aspects of therapeutic antibodies and to discuss their projects and ideas face-to-face with experts in the field. A unique component to this conference that distinguishes it from other more commercial meetings in the field, is that this conference will include presentation and discussion of novel/unpublished data.

Public health relevance
PROJECT NARRATIVE The field of antibody immunotherapeutics has expanded exponentially over the last two decades and this progress is likely to continue. Researchers are making significant progress in developing new technologies to overcome limitations of production and are now in an era of plug and play design. The ever-growing interaction between academia and industry, which conferences such as this foster, is central to providing new avenues for improving human health.